Neurofibromin 1 as a novel regulator of lipid metabolism

PROJECT SUMMARY
High grade gliomas (pHGGs) represent the greatest number of solid tumors in the pediatric population, and now
are the greatest cancer related cause of death. Within the past 20 years, treatment progress has remained
stagnant, as 5-year survival rates remain less than 20%. Ras signaling has been shown to be highly upregulated
in many pHGGs, although Ras mutations are very rare. The role of negative regulators of Ras signaling, Ras
GAPs, in pHGGs remain vastly understudied. We discovered that Neurofibromin 1 (Nf1) is a Ras GAP commonly
mutated in 10% or higher of pHGGs. Additionally, 1 in 3000 individuals per year are born with Neurofibromatosis
Type I, a tumor predisposition syndrome with somatic heterozygous NF1 mutation. These individuals are at
greater risk for developing a number of cancers, including brain tumors. We leveraged pHGG transcriptomic and
proteomic datasets and GSEA pathway analysis and identified that alterations in cellular metabolism correlate
with NF1 loss in pediatric high grade gliomas, specifically through vast changes in lipid content.
I hypothesize that NF1 is a critical regulator of lipid metabolism, and that metabolic intervention could be used
to treat NF1 driven gliomas. My goal during the remainder of my graduate training (F99 phase) is to elucidate
how NF1 loss alters fatty acid/lipid metabolism, and whether targeting this phenotype in pHGG models is
efficacious. Upon finishing my graduate training, I will identify a post-doctoral mentor (K00) and further
investigate the metabolic roles of NF1 on brain tumor epigenetics. The proposed project leverages in vitro and
in vivo systems to study a distinct metabolic phenotype at the cellular and tumor levels. Our research will inform
a molecular mechanism and translational relevance for a role of NF1 in lipid metabolism. This data could also
be applicable to other cancer types and tumor predisposition syndromes. Combined together, the two phases of
this award will provide me with the means to establish myself as a successful cancer researcher and enable
me to lay the foundation for my own independent cancer research laboratory predicated on intertwined
study of brain tumor biology, neuroscience, and metabolism.

Public health relevance
PROJECT NARRATIVE High grade gliomas are aggressive brain tumors that occur in children and, with limited therapeutic options, are highly lethal. We have discovered a novel function for a protein commonly mutated in pediatric high grade gliomas, which leads to distinct changes in metabolism of the neural progenitor and tumor cells. Our proposed study seeks to understand how this protein regulates lipid metabolism specifically, and whether this distinct change can be targeted to improve therapeutic intervention.